In vitro and in vivo modeling of gene therapy vector stability when challenged by natural virus infection in human hepatocytes

PROJECT SUMMARY
Gene therapies based on adeno-associated virus (AAV) vectors have been a revolutionary medical
advancement in treating human genetic diseases. With a single dose, AAV-mediated gene therapies can
confer long-term correction or abatement of disease for the lifetime of the patient. Recombinant (r)AAVs that
are used for the transfer of therapeutic genes are considered safe, partly because these vectors are removed
of all viral genes. The only viral elements that are retained are the inverted terminal repeat (ITR) sequences
that are at both the ends of the vector genome. However, this feature may make them vulnerable to natural
viral infections from wildtype (wt)AAV and helper viruses, such as adenoviruses (AdV), herpesviruses, or
papillomaviruses. It is speculated that these challenges may destabilize the therapeutic vector genome or may
amplify them in a process called “mobilization”. Unfortunately, models for these events have yet to be explored,
and the extent to which these processes can alter the abundance or structure of the vector genomes are
unknown. Understanding the stability of rAAV genomes in treated tissues under these naturally occurring and
unavoidable circumstances is critically important for the gene therapy field.
This project proposal aims to define if and how natural virus infections that can act to alter the composition
of AAV-based gene therapy in human hepatocytes, a prevalent gene therapy target for rAAV-based
treatments. The objectives are to develop novel methods to characterize the structure of vector genomes as
they transition from linear species, to extrachromosomal episomes, and to vector genomes that have
integrated into the host cell genome. The bases of this work leverages expertise in long-read sequencing
technologies, bioinformatics, and vectorology to address these decades-long unanswered questions. The grant
proposal is divided into two main aims:
• Aim 1. Track changes in vector genome abundance and episomal configurations within transduced
primary human hepatocytes following wtAAV and wtAdV infection. A relevant in vitro model will be
developed to track the kinetics of transgene expression and to assess the stability of rAAV genomes in
transduced human hepatocytes following wtAAV and wtAdV infection over time.
• Aim 2. Assessing the ability for wtAAV and wtAdV infection to destabilize rAAV episomes in
humanized mouse livers. Whether wtAAV and wtAdV infection will act to destabilize or mobilize rAAV
genomes in human hepatocytes, or whether they will act to drive integration of vectors into the host cell
genome will be tested in the Fah/Rag2/Il2rgc-deficient (FRG)-humanized liver mouse model.

Public health relevance
PROJECT NARRATIVE This project proposal seeks to define if and how natural virus infections alter the composition of gene therapy vectors in treated cells and tissues, and in turn impact the stability and expression profile of therapeutic transgenes. Using next-generation sequencing approaches and appropriate cell culture and animal models, this work will help to define the stability of adeno-associated virus (AAV) vector genomes in human hepatocytes following natural virus infections by AAV and adenovirus (AdV). The project will help to inform whether gene therapy recipients are at risk of losing the therapeutic vector and/or result in transgene-related genotoxicity when exposed to natural virus infections.